Treatment Phenotypes for Adolescents with Asthma

PROJECT ABSTRACT
Asthma is the most common chronic disease of childhood, and asthma related morbidity costs the US medical
system tens of billions of dollars every year. Adherence to asthma medications (specifically inhaled
corticosteroids) has been shown to improve asthma related outcomes. Dr. Hoch will evaluate medication
usage patterns in depth over one year and develop an intervention with the input of adolescents and providers
to improve asthma adherence and control. Dr. Hoch’s overarching hypothesis is that medication adherence
trajectory patterns will exist, and that the qualitative analysis will yield actionable ideas for a personalized
intervention, aimed at each child’s specific medication use pattern. The purpose of this application is to assist
Dr. Hoch in her transition into an independent, federally funded researcher. To this end, Dr. Hoch will use this
award to gain additional training in 1) research study methods, including recruitment and retention of subjects
and longitudinal data collection, 2) qualitative research methods and 3) the conduct of pragmatic trials in
behavior change. She is uniquely positioned within the University of Colorado Anschutz Medical Campus to
conduct this work. She will be supported both by the research infrastructure at the University of Colorado
School of Medicine and Children’s Hospital Colorado, as well as the Adult and Child Consortium for Health
Outcomes Research and Delivery Science (ACCORDS) center. Through these two institutions, she will be
guided by a group of internationally recognized researchers, including Dr. Stanley Szefler (Primary mentor and
asthma clinical trials expert), Dr. Allison Kempe (health services research mentor and pragmatic trials expert),
Dr. Jodi Holtrop (qualitative and mixed methods research expert) and Dr. Angela Bryan (health behavior
change expert). In order to accomplish Dr. Hoch’s short term research goals, she proposes a project with the
following specific aims: 1) To better characterize adherence trajectory phenotypes, and to combine
adherence with short acting beta agonist (SABA) use patterns to create defined asthma treatment
phenotypes, 2) Use qualitative methods among adolescents and providers to evaluate reasons for
adherence/nonadherence and motivating factors for adherence, feelings about device monitoring and
suggested strategies for intervention among each of the highest risk treatment phenotypes using a
self-determination theory framework, 3) To develop and pilot test an intervention strategy using the
RE-AIM framework, with a focus on the highest priority treatment phenotypes (those with poor
adherence/poor control, and those with good adherence/poor control). This approach will yield lessons
that will be helpful for the future treatment of asthmatic children by personalizing treatment based on
medication use patterns, and train Dr. Hoch for her career as an independent researcher.

Public health relevance
PROJECT NARRATIVE Technology has become available that allows for medication usage tracking for adolescents with asthma, who are at high risk for medication non-adherence. This project seeks to evaluate medication usage patterns in adolescents with asthma, utilize in-depth interview techniques to understand how to improve medication use and create interventions tailored to each individual. We will then test these interventions to see how feasible they are for implementation in the clinical setting.